Ultra-fast imaging for the safe delivery of electron FLASH radiation therapy

Abstract
Radiation therapy is a supplementary curative treatment used adjuvant with most surgery and chemotherapy,
being delivered to nearly 1 out of every 4 people in their lifetime. While image guidance and conformal planning
reduced the dose to healthy tissue, there is still a substantial risk of tissue damage that sets the upper limit of
dose deposited to the tumor. Recently the minimization of healthy tissue damage was demonstrated to occur
when ultra-high dose rates (UHDR) were used for irradiation, known as the FLASH effect. UHDR are defined as
a complex set of high average dose rates (>40 Gy/s), instantaneous dose rates (>106 Gy/s), total dose values
(>8Gy) and temporal pulse structures. FLASH promises a reduction in normal tissue toxicity by 20-50% and our
clinical site partner Dartmouth-Hitchcock, has been the first to demonstrate routine weekly delivery of FLASH on
a clinically used linac. This modification shows enormous translational potential to deliver electron FLASH
(eFLASH) in any radiotherapy center using existing systems. However, while most research in the field is focused
on elucidating the radiobiological mechanisms of FLASH, work towards mitigating the risks of FLASH is largely
untouched, yet will be pivotal for wider clinical implementation. New techniques for detection monitoring of
radiation need to be developed due to the millisecond timescales at which FLASH operates which make
traditional methods unsuitable. In this project, we have leveraged our camera platform, BeamSite®, the world’s
first video system for radiotherapy, now FDA cleared and in use clinically, to developed BeamSite-ULTRA,
specifically for imaging FLASH. In our Phase I grant, we successfully demonstrated the ability to image at the
high frame rates and transfer speeds necessary to capture a single beam pulse energy in phantoms and on
tissue. In this Phase II, we will advance BeamSite-ULTRA as a robust, manufacturable, and FDA clearable
commercial system. We will quantify both spatial and temporal pulse structures, demonstrate beam-on and
gating-off potential of the system, and establish the capabilities in both proton and electron FLASH clinical
settings. The work includes an extensive team of industry and academic medicine colleagues, using the eFLASH
resources at Dartmouth-Hitchcock Medical Center and the proton treatment facilities at the University of Kansas
Medical Center.

Public health relevance
Narrative The recent advances in FLASH radiotherapy mark a sea change in the way radiotherapy could be delivered but also have the potential to introduce new dangers. Tools to monitor and verify the accurate and consistent delivery of FLASH do not exist today. At DoseOptics, we leverage our world leading Cherenkov detection system, BeamSite® for conventional radiation therapy and develop BeamSite ULTRA, a system suitable to accurately characterize of treatment beams, temporally and spatially, for the ultra-high dose rates used in FLASH. By developing the system for both electron and proton treatments, BeamSite ULTRA will help to ensure accurate delivery, reduce misadministration events, and improve treatment outcomes.